Mentored patient-oriented research in disparities in cardiovascular and kidney disease

PROJECT SUMMARY
Dr. Gutiérrez is an Associate Professor of Medicine and Epidemiology, Section Head of Outcomes and
Epidemiology research in the Division of Nephrology, and Medical Director of the Bionutrition Unit in the Center
for Clinical and Translational Science (CCTS) at the University of Alabama at Birmingham (UAB). The long-
term scientific goal of Dr. Gutiérrez is to build a patient-oriented research (POR) program focused on
identifying novel strategies for reducing or eliminating disparities in health outcomes related to cardiovascular
disease (CVD) and chronic kidney disease (CKD). In order to accomplish this goal, Dr. Gutiérrez recognizes
the critical importance of mentoring the next generation of clinician scientists who can develop the necessary
expertise to investigate root causes of disparities in a comprehensive and ethical manner. However, the
increasing demands on his time related to sustaining his professional effort for research as well as
administrative and supervisory commitments pose a challenge towards his ability to grow his mentorship
activities. This award will ensure Dr. Gutiérrez maintains the protected time to focus on POR related to
disparities in CVD and CKD, a central component of which will involve mentoring junior investigators. His
trainees will receive comprehensive training in POR centered on three main projects which focus on (1) the
role of disordered mineral metabolism, (2) nutrition, (3) and novel pathways of kidney injury in explaining racial
differences in CVD and CKD outcomes. This activities will be coupled with a robust program to enhance his
skills as a mentor, with the ultimate goal of producing well-trained investigators committed to POR focused on
disparities in health outcomes.

Public health relevance
PROJECT NARRATIVE Disparities in cardiovascular and kidney disease are among the biggest drivers of excess mortality in racial and ethnic minorities in the United States, costing billions of dollars a year. There is a need for investigators who have the appropriate training in patient-oriented research to identify reasons for disparities in cardiovascular and kidney disease and devise ways to overcome them. This award would allow Dr. Gutierrez, a successful mid-career investigator, the ability to devote more time to mentoring the next generation of clinical investigators committed to patient-oriented disparities research.